Enhancing the HemOnc Knowledgebase of Chemotherapy Drugs and Regimens

Project Summary
Systemic cancer treatments have transformed the landscape for many patients with cancer, yet
are toxic and often given in complicated combinations and protocols. In 2011, we began to build
the HemOnc.org website as a free and open resource for hematology and oncology healthcare
professionals. HemOnc.org contains granular information on anti-cancer drugs, regimens, and
guidelines, and is now the largest resource of its kind. In 2020, there were >250,000 unique
visitors and >1,000,000 pageviews from 181 countries. Users are primarily split between clinicians
and pharmacists, with utilization by trainees as well as experienced practitioners. Translational
researchers also utilize the site as a source of domain knowledge. Beginning in 2017, we
formalized the structure of much of the content on HemOnc.org, enabling its transformation into
a structured vocabulary, HemOnc. As of January 2021, HemOnc comprises 83,879 concepts
across 30 concept classes, and 223,039 relationships across 45 relationship types. Explicit
mappings exist between HemOnc and RxNorm, CanMED, SNOMED-CT, OncoTree, and the NCI
Thesaurus. Several organizations and projects actively utilize or are evaluating HemOnc,
including AACR Project GENIE, the ITCR-funded DeepPhe project, the Variant Interpretation for
Cancer Consortium, and cBioPortal. In addition to maintaining the steady growth in content that
has taken place over the past nine years, we aim to enhance the HemOnc.org website and
HemOnc ontology through the following five specific aims: 1) present interactive ranked regimen
graphs on the website; 2) allow for dynamic temporal exploration of regimens, studies, and
authors with an interactive Regimen Browser; 3) grow and refine the HemOnc ontology; 4) build
structured summaries and narrative synopses for the most important anticancer regimens,
including identification of regimens specifically evaluated in underrepresented populations; 5)
cultivate a robust user community. This work will be undertaken by an accomplished team of
clinicians and translational researchers.

Public health relevance
Project Narrative The treatment of cancer is very complex, with thousands of treatment options across hundreds of types of cancer. In order to organize this information in a way that is usable for healthcare providers and translational researchers, we created the HemOnc.org knowledgebase, which is now the largest resource of its kind. This project seeks to maintain and enhance HemOnc.org for the benefits of clinicians, researchers, and patients.